Short-Term Training Program to Increase Diversity in Health-Related Research

DESCRIPTION (provided by applicant): The Brown University Short-Term Training Program supports the training of 15 under-represented (minority and disadvantaged) undergraduate students each year to complete 9-week, faculty mentored summer research internships. The program recruits students from a national pool and provides them with early research training experience in cardiovascular, pulmonary, hematologic and sleep disorders research. This program has existed at Brown for the past 18 years. Over the life of the program 1 of every 15 trainees mentored has become a faculty member and ~3 of every 15 trainees mentored has earned advanced terminal graduate degrees such as the M.D. /PhD, or the PhD degree. The current proposal seeks renewal of this successful program. By doing so, we will continue to replenish and diversify the biomedical fields by supporting the training of under-represented racial & ethnic minorities, disabled and other disadvantaged individuals. This will be achieved by providing students from these under-represented groups with a) research training experiences with outstanding faculty mentors at Brown, b) enriching peer mentoring and self-affirming activities led by UR graduate students from the same backgrounds and c) engaging in activities that model the career lifestyle and habits of scholars. The latter includes participating in research forums, attending and participating seminars and engaging in social activities. The participatory learning activities of our program will help to motivate trainees to pursue careers i the biomedical sciences. Moreover, by continuing this program we will expand the research opportunities & training experiences for under-represented students that would otherwise not be available to them. This will help to foster a stronger and more career oriented outlook among participants. Inevitably, this will help to preserve the U.S. global competitiveness in the areas o science, medicine, healthcare technology and education. (End of Abstract)

Public health relevance
Project Narrative This project will address the need to improve domestic scientific excellence so as to ensure that the U.S. is able to engage in scientific practices that are consistent with our future needs in the areas of biomedical research, healthcare advances and education. It will achieve this goal by providing training to undergraduate college students who are racial and ethnic minorities, disabled individuals and socioeconomically disadvantaged individuals. The project will implement strategies that strengthen education and address student needs, which impact their retention and interests leading to biomedical careers. The program will work to keep student trainees on a trajectory that will help them seamlessly transition from the undergraduate career stage to more advanced stages. Finally, it will instill self- confidence that leads to success, which they will model for future students considering similar career pursuits.